Evaluation of a Novel mHealth Intervention for People Who Are Ambivalent About Quitting Smoking: A Randomized Controlled Trial

PROJECT SUMMARY
Tobacco use remains the leading preventable cause of death and illness in our society and causes 30% of
cancer deaths. Despite this, 28.3 million US adults smoke. Most of them (70%) want to quit smoking someday, but
are not yet ready to quit or actively seeking treatment--they are ambivalent about quitting. Available evidence-based
stop-smoking treatments (medication and counseling) are not typically offered to people who are ambivalent about
quitting smoking (PAQS) due to cost and limited resources, but to meaningfully reduce smoking prevalence, low-
cost, scalable interventions are needed that can effectively engage PAQS, encourage them to stop smoking, and
support them through this process, including connecting them to available evidence-based treatment when they are
ready to quit. The current proposal is responsive to this public health goal and to NCI’s call for innovative, scalable
mobile health (mHealth) smoking cessation interventions. Building on our programmatic work developing digital
therapeutics for smoking cessation, population-level motivational interventions, and user-centered design and
development work with PAQS, we designed a mHealth app (called GEMS) which blends sound scientific theory,
evidence-based treatment, and best practice recommendations with novel, theory-based content that is responsive
to the needs and preferences of PAQS. The backbone of the intervention is a series of sequential, self-guided
exercises (called ‘personal experiments’) designed especially to help PAQS clarify their health goals; build and
strengthen their motivation and confidence for quitting smoking; and teach them the skills necessary to change their
smoking behavior. This content is paired with action-oriented guidance how to quit, an ability to earn free nicotine
replacement therapy (NRT), and in-app direct access to free evidence-based tobacco quitline counseling, as well
other tools designed to enhance engagement with the app, motivation, and self-efficacy. Findings from a recent
randomized pilot of GEMS (n = 57) were positive. Compared to an identical version of the app without the personal
experiments, GEMS was used more often, more users earned the free NRT and requested this treatment, and
more accessed free quitline counseling within the app. Moreover, twice as many GEMS users reported smoking
abstinence at follow-up. We now propose to test the efficacy of GEMS in a fully-powered randomized controlled trial
(n=800) using nationwide recruitment via social media and from a large health care system to recruit a diverse,
representative sample of PAQS. Co-primary outcomes will be objectively measured requests for either NRT or
quitline counseling accessed through the app and smoking abstinence at 6-months post-enrollment. App utilization,
smoking reduction, and other tobacco or treatment use will also be examined. GEMS is the first known app
designed exclusively for PAQS. If effective, it could provide a novel, highly scalable tool for increasing treatment use
and smoking abstinence among PAQS, thereby addressing a significant and under-researched public health gap.

Public health relevance
NARRATIVE Each year, smoking kills 8 million people worldwide. Developing scalable, population-level behavioral treatments for smoking cessation is a priority of the National Cancer Institute (NCI) and aligned with the White House’s Cancer Moonshot goal to reduce smoking. This project addresses those priorities by testing the efficacy of a promising mobile health (mHealth) app designed exclusively for people who are not yet ready to quit smoking—the majority of people who smoke. To date, there are currently no effective population-based interventions for this critical group. If this novel intervention is found effective, it could be broadly disseminated, help reduce smoking prevalence, and inform the optimal design of future interventions targeting people who are not yet ready to quit smoking.